The role of REDD1 in insulin-mediated transcription

Project Summary/Abstract
Type II diabetes (TIID) is the most prevalent form of diabetes and doubles a patient’s risk for cardiovascular
disease (CVD) heart failure, independent of additional risk factors. In fact, CVD that occurs in patients with TIID is
termed, ‘diabetic cardiomyopathy’ (DC). While impaired cardiac insulin signaling, or insulin resistance, is a major
factor in DC pathogenesis, current therapies focus on reducing blood glucose versus restoring insulin sensitivity.
Our overall objective to identify the major mediators of cardiac insulin sensitivity and resistance in an effort to
identify novel therapeutic targets for DC. Using unbiased genome-wide approaches, we uncovered ‘regulated in
development and DNA damage 1’ (Redd1, also known as Ddit4) as the most transcriptionally active, insulin-
inducible gene in the murine heart. This correlated with insulin-inducible increases in REDD1 gene and protein
expression. REDD1 is an established inhibitor of mTORC1 signaling, however, the mechanisms by which this
occurs remain unclear. In addition, REDD1 has been implicated in both insulin sensitivity and resistance, but with
no consensus. Our preliminary data demonstrate that, in addition to insulin, fatty acids and high fat diet (HFD)
selectively induce REDD1 expression. We also show that insulin increases, while HFD prevents, REDD1 nuclear
localization in the heart. Our data also outline a novel potential mechanism whereby insulin increases REDD1
expression, nuclear localization, and chromatin binding, enhancing the transcription of REDD1-bound oxidative
metabolic genes and inhibiting the transcription of REDD1-bound autophagic and mitophagic genes in the heart. It
is our central hypothesis that high fat drives insulin resistance by preventing insulin-mediated REDD1 nuclear
localization, which results in suppressed oxidative metabolism and activated autophagy and mitophagy, mainly via
loss of nuclear REDD1-dependent transcriptional regulation, as well as enhanced mTORC1 inhibition. We will test
this hypothesis with three specific aims. We will (1) determine the cytosolic role of REDD1 in mediating cardiac
insulin resistance, (2) investigate the mechanism of REDD1 nuclear localization and its role in mediating cardiac
insulin sensitivity, and (3) examine the effects of REDD1 on insulin-dependent cardiac transcription and gene
expression. Here, we will use a novel mouse model with cardiomyocyte REDD1 deletion, as well as isolate these
cardiomyocytes for in vitro studies. These mice or cardiomyocytes will be subjected to high fat to induce insulin
resistance, using well established models. We will also employ four novel REDD1 mutants to examine the
contributions of REDD1-dependent mTORC1 inhibition, nuclear localization, and chromatin binding to cardiac
insulin sensitivity versus resistance. Overall, we expect that high fat will prevent insulin-inducible nuclear
localization, chromatin binding, and activation of oxidative metabolic and suppression of autophagic and mitophagic
genes. Accordingly, we predict that this is a major mechanism by which high fat drives insulin resistance. These
studies are critical as we predict that restoring nuclear REDD1 will restore insulin sensitivity and prevent cardiac
dysfunction. Investigation of these critical pathways is essential for the developing novel therapies for TIID and DC.

Public health relevance
Project Narrative There is currently no ideal therapy for type II diabetes (TIID), the most prevalent type of diabetes, which doubles a patient’s risk for cardiovascular disease (CVD) and death due to CVD. In this proposal, we will examine the molecular mechanisms by which a high fat diet induces insulin resistance in the heart, as obesity is thought to be its main cause. This information will allow for the development of new and effective therapies to prevent CVD in patients with TIID.